Role of Chromatin Bridges in Activating Innate Immune Signaling following Failed Mitosis

PROJECT SUMMARY/ABSTRACT
Abnormal chromatin structures produced by errors in cell division can cause cell death, propagate genetic
instability and, potentially, induce inflammatory signaling. Micronuclei and chromatin bridges (CBs) are two
types of abnormal structures which are frequently observed in cells from cancers and cancer-related diseases
such as Blooms Syndrome (BS). Aberrant chromatin structures can expose genomic self-DNA to the
cytoplasm which activates anti-viral inflammatory signaling. Cytoplasmic self-DNA (cyDNA) triggers type-1
interferon (IFN) signaling through multiple innate immune pathways, of which the cGAS-STING axis is most
prominent. However, only micronuclei have been studied for their potential to induce IFN signaling. Prior
reports suggested that micronuclei spontaneously rupture and produce cyDNA which then activates cGAS.
Surprisingly, I have identified that CBs, not micronuclei, are responsible for cGAS activation and IFN induction
after failed mitosis. I propose to investigate the molecular and physical mechanisms underlying cGAS
activation by CBs. I will use drug-induced mitotic failure or cellular models of BS to study CBs. I will investigate
how cGAS-activating CBs arise from errors in cell division, how CBs activate cGAS and whether cGAS-
activating CBs are generated in cellular models of BS. I hypothesize that inflammatory CBs are formed by
unresolved catenations or merotelic attachments and activate cGAS through a tension-dependent mechanism.
To test this hypothesis, I first will analyze CBs produced by drug-induced mitotic failure to determine their
formation mechanism. I then will generate CBs through alternative methods, such as topoisomerase inhibition,
to determine whether these CBs similarly activate cGAS. In my second aim I will investigate whether actin-
mediated tension across the CB is required for cGAS activation. I will test my hypothesis that tension on CBs
facilitates cGAS activation through the extrusion of chromatin-bound proteins. In aim 3 I will study cellular
models of BS. BS is an inherited cancer pre-disposition syndrome characterized by chromosomal instability
and frequent CBs. BS is caused by loss of function mutations in the BLM helicase and cells with a defective
BLM helicase exhibit a high number of unresolved sister chromatid catenations during anaphase. I will study
whether these catenations turn into cGAS-activating CBs, and if this occurs through the tension-dependent
mechanism identified in aim 2. The Mitchison lab provides me an excellent space to explore the nexus of
mitotic mechanisms and innate immune signaling. We have made important discoveries in the biology of
mammalian cell division and the mechanisms of anti-mitotic chemotherapy. I propose to partake in this tradition
by studying the inflammatory consequences of mitotic failure and its potential role in the pathology of Blooms
Syndrome.

Public health relevance
Project Narrative Mitotic errors and inflammation are two hallmarks of cancer and cancer-associated diseases which may be causally related. Abnormal chromatin structures, such as micronuclei and chromatin bridges, are produced after defective cell division and have been proposed to activate anti-viral DNA sensors and induce inflammatory signaling. The studies described here will determine how chromatin bridges form after drug- induced mitotic failure, investigate the mechanism by which they activate the anti-viral DNA sensor cGAS, and test whether this mechanism occurs in cellular models of Blooms Syndrome.